Phenotypic characterization of T’Ho virus and the development of tools for its serologic diagnosis

PROJECT SUMMARY
T’Ho virus is a poorly characterized flavivirus recently discovered in Culex quinquefasciatus mosquitoes in the
Yucatan Peninsula of Mexico. The genome of T’Ho virus was fully sequenced but an isolate was not recovered by
suckling mouse brain inoculation or by virus isolation in vertebrate or mosquito cell cultures. Genome sequence
alignments revealed that the closest known relatives of T’Ho virus are mosquito-transmitted flaviviruses
associated with life-threatening human disease. Rocio virus, a BSL-3 pathogen, is the closest known relative,
followed by Ilhéus, St. Louis encephalitis, Japanese encephalitis and West Nile viruses. Because T’Ho virus is most
closely related to known human pathogens, it too could be a cause of human disease. Clinical and serological
studies need to be performed to investigate this issue. There is also an important need to perform in vivo
experimental infections to identify competent vertebrate host and vector species. The ability to perform these
experiments is severely restricted by the unavailability of an isolate. To address this issue, recombinant technology
will be used to create infectious viruses that can be used for T’Ho virus research and diagnosis. The first objective
is to generate recombinant T’Ho virus and characterize its in vitro host range and replication kinetics. Based on its
close phylogenetic relationship with flaviviruses that cycle between mosquitoes and vertebrate hosts, it is
hypothesized that T’Ho virus replicates in both mosquito and vertebrate cells. The second objective is to create a
chimeric virus that can be used in BSL-2 laboratories for the detection of neutralizing antibodies to T’Ho virus.
Because T’Ho virus is closely related to several BSL-3 pathogens, it could eventually be classified as a BSL-3 agent.
However, many arbovirus laboratories, particularly those in Latin America, lack BSL-3 facilities. Therefore, a
chimeric virus will be generated by substituting the major structural protein genes of Zika virus, a BSL-2 pathogen,
with the corresponding region of T’Ho virus, producing a virus that can be used in BSL-2 laboratories. It is
hypothesized that the aforementioned genetic exchange is functionally compatible and will generate a chimeric
virus that forms plaques in vertebrate cell monolayers. The proposed studies provide the foundation for many
future experiments. Vertebrate animals and mosquitoes can be experimentally inoculated with the recombinant
virus to identify competent reservoir hosts and vectors of T’Ho virus, providing insight into its transmission cycle.
The recombinant virus will allow researchers to monitor humans and vertebrate animals in Mexico and elsewhere
in the Americas for antibodies to T’Ho virus by plaque reduction neutralization test (PRNT). The PRNT is the gold-
standard serologic technique for the diagnosis of flavivirus infections and it requires live virus. The chimeric virus
can be used when BSL-3 facilities are unavailable. Flaviviruses are known for their serologic cross-reactivity; thus,
it is likely that antibodies to T’Ho virus can bind to and neutralize other flaviviruses. This raises the possibility that
some human and vertebrate animals previously tested by PRNT in serologic investigations in Latin America
contained antibodies to T’Ho virus but were misdiagnosed. It is important that infectious T’Ho virus is available so
it can be included in PRNTs and considered in the differential diagnosis.

Public health relevance
PROJECT NARRATIVE This project will generate recombinant T’Ho virus and a chimeric virus that expresses the major structural proteins of T’Ho virus and will provide fundamental data on the in vitro host range and replication kinetics of this newly discovered flavivirus. The project also provides the groundwork for future in vivo experimental infections, allowing competent vectors and reservoir hosts to be identified, and future serosurveillance studies, allowing the natural host range, seroprevalence and geographic distribution of the virus to be determined. Although the genome of T’Ho virus has been fully sequenced, an isolate is unavailable and therefore the importance of the proposed study cannot be understated.